A PRION REVEALS COMPLEX TRAITS AND PHENOTYPIC DIVERSITY

DESCRIPTION (provided by applicant): Proteins must adopt the correct folded structure for full functionality. For some proteins, post-translational modifications have a tremendous impact on both the structure and the function of the protein. Structural regulatory control of protein function has been well- established in many facets of biology and is often a key control step in signal transduction events that are essential for life, such as the response to nutrients and stresses, cell cycle progression, and proliferation. However, unexpected alterations in protein structure can be detrimental. Misfolded proteins are frequently associated with irreversible loss-of-function and disease instead of regulation. Protein misfolding and aberrant polymerization have been implicated in many neurodegenerative disorders including Parkinson's, Alzheimer's, Huntington's, and prion diseases. We are investigating how a group of proteins adopt a specific type of "misfolded" state (prion conformation) as a regulatory mechanism. These proteins may have evolved with the intrinsic ability to produce major changes in conformation as a means of regulation. This mechanism (prion propagation) provides an epigenetic switch that is self-perpetuating and is transmitted from mother cells to their daughter cells when the prion protein is transmitted through the cytoplasm. Due to their unique mode of propagation and inheritance, these prions have a profound impact on the ability of the organism to alter its phenotypes and adapt to changing environments. These prion proteins may represent remnants of an ancient regulatory mechanism that is still maintained in the budding yeast Saccharomyces cerevisiae. We now have evidence to suggest that phenotypic adaptation can be regulated by a network of prion proteins in yeast. Elucidating the underlying mechanistic principles of this epigenetic mechanism of regulation is a key first step in revealing the global impact of this type of regulation on protein expression to alter phenotypes, adaptation, and survival. PUBLIC HEALTH RELEVANCE: Proper regulation of gene expression is required for normal development and cellular physiology. The loss of regulation can result in either the overexpression or insufficient expression of gene products, which in turn can lead to unregulated cell growth or premature cell death. These processes are associated with invasion of pathogens such as viruses, many human diseases, including cancer and metabolic problems.

Public health relevance
Proper regulation of gene expression is required for normal development and cellular physiology. The loss of regulation can result in either the overexpression or insufficient expression of gene products, which in turn can lead to unregulated cell growth or premature cell death. These processes are associated with invasion of pathogens such as viruses, many human diseases, including cancer and metabolic problems.